Epigenetic regulation of exhausted CD8 T cells via the miR-29a-TET2 axis

Chronic infections and cancer cause CD8 T cell exhaustion, a differentiation state characterized by the inability
of CD8 T cells to provide immunological protection. Improving the function of exhausted T cells (TEX) by
antagonizing checkpoint inhibitors is a potent immunotherapeutic strategy. However, most patients do not exhibit
long-term protection, creating a need for improved immunotherapeutic strategies. Resistance to immunotherapy
is mainly attributed to the inability of checkpoint inhibitors to reverse the TEX epigenome. Therefore, epigenetically
re-directing TEX differentiation to induce durable responses is key to overcoming resistance to immunotherapy.
To date, modifying a single transcriptional pathway has had limited success in providing full TEX
reinvigoration and inducing long-term persisting immune responses. Instead, microRNAs (miRs) can have a
profound impact on the epigenetic regulation of immune cells; however, the role of miRs in TEX differentiation is
understudied. We recently identified miR-29a as a unique memory-associated miR that is repressed in TEX. We
demonstrated that ectopic expression of miR-29a enhances TEX persistence, attenuates their exhaustion,
and promotes differentiation of a TEX subset with progenitor, stem-like characteristics that responds to
immunotherapy. Importantly, our preliminary data suggest that miR-29a alters the epigenetic profile of TEX and
promotes durable CD8 T cell responses, in striking contrast to anti-PD-L1 therapy. Mechanistically, we
demonstrate that miR-29a directly targets the key DNA demethylating enzyme TET2 and that TET2
overexpression abrogates key effects of miR-29a in TEX differentiation. However, the molecular circuits involving
miR-29a and TET2 and the implication of miR-29a-TET2 axis in checkpoint inhibitor therapy is unknown. The
goal of this proposal is to uncover the role of miR-29a in targeting the key epigenetic modulator TET2
and, thus, define the role of miR-29a in synergizing with checkpoint inhibitors. Our central hypothesis is
that miR-29a regulates DNA methylation by directly targeting TET2, therefore, synergizes with checkpoint
inhibitors to re-direct TEX differentiation.
Aim 1. Identify the role of the miR-29a-TET2 axis in regulating TEX differentiation. We hypothesize that miR-
29a regulates DNA demethylation, by directly targeting TET2, thereby fundamentally alters TEX differentiation.
We will elucidate the TET2-dependent versus TET2-independent effects of miR-29a in TEX differentiation and
the downstream effects in DNA methylation.
Aim 2. Identify the pathways by which miR-29a synergizes with anti-PD-L1. We hypothesize that miR-29a
epigenetically alters the differentiation of the progenitor TEX subset and, thereby, synergizes with anti-PD-L1 to
promote durable TEX reinvigoration. We will elucidate the molecular mechanisms of synergy between miR-29a
and anti-PD-L1 and we will define the TET2-dependent and TET2-independent roles of miR-29a in synergizing
with anti-PD-L1 in mouse models of LCMV and B16 melanoma.

Public health relevance
Chronic infections and cancer result in dysfunction of immune cells, termed “exhaustion”. With this proposal, we will investigate the cellular and molecular mechanisms that cause exhaustion and the use of a small non-coding RNA (microRNA-29a; miR-29a) to overcome exhaustion. We will explore the potential of delivering miR-29a to T cells as a novel strategy to improve responses to immunotherapy.